METABOLIC EFFECTS ANESTHESIA SURFACE COOLING NEONATES UNDERGOING CARDIAC SURGERY

This study will distinguish the influence of anesthesia, passive cooling, and nonshivering thermogenesis on the development of metabolic acidemia noted in newborn infants undergoing cardiac surgery.